Direct Targeting of MYC in Cancer with Hyperstable Synthetic Transcriptional Repressors

PROJECT SUMMARY
Transcription factors (TFs) are master regulators of gene expression and have been implicated in many disease
states, including in cancer. Of these, the basic helix-loop-helix (bHLH) MYC TF family members are notorious
drivers of oncogenic expression programs and are implicated in approximately 70% of all cancers. TFs influence
gene expression by binding to their cognate DNA sequences and recruiting the appropriate transcriptional
machinery to activate or inhibit gene expression. Although TFs are well-validated targets for cancer therapeutics,
the featureless nature of the protein-protein and protein-DNA interactions required for their function is resistant
to traditional drug development pipelines. Indeed, some small molecule inhibitors of bHLH-TF proteins have
been reported, but their low potency and unclear mechanism of action have stalled their translation into clinical
use. To address this challenge, we have developed a platform of fully synthetic, modular TF mimetics. Our
approach employs strategic chemical stabilization of peptide secondary, tertiary and quaternary structure to yield
synthetic transcriptional repressors (STRs) capable of binding target DNA sequences with high affinity and
specificity. The initial class of STRs, derived from the bHLH protein MAX, inhibit MYC/MAX-DNA binding and
block MYC-driven oncogenic phenotypes in cells. Building upon these preliminary data, this proposal aims to
explore and expand into novel STR architectures and validate lead STRs capable of opposing oncogenic gene
expression programs and phenotypes in animal models of MYC-driven cancers. Our expertise in synthetic
chemistry and biochemical profiling of TF function, as well as our established collaborations with leaders in the
fields of epigenetic and transcriptomic profiling and in vivo imaging, will be leveraged in the service of the
following specific aims: 1) structural and biochemical optimization of hyperstable and ultrapotent STRs targeting
MYC, 2) enhancing cellular and pharmacologic delivery of STRs coupled with quantitative mapping of STR-
reprogramming of epigenetic and transcriptomic landscapes in MYC-dependent cancer cells, and 3) evaluation
of lead STRs in in vivo models of both MYC-dependent solid tumors (neuroblastoma) and liquid cancers
(lymphoma). Successful completion of these aims will generate potent, specific, and pharmacologically tenable
STRs and prioritize them for further study as MYC-targeted therapeutics. Beyond this direct goal, this work will
provide new insight into MYC-mediated gene regulation in cancer and establish a blueprint for the development
of STRs targeting other TF-dependent gene expression networks in the future.

Public health relevance
Project Narrative. The MYC family of transcription factors (TF) are notorious drivers of many cancers but have been resistant to traditional drug discovery strategies. To address this challenge, we have developed a new type of molecule, synthetic transcriptional repressors (STRs)m that specifically bind to the same DNA sequences as MYC proteins, thereby inhibiting MYC function in cancer cells. Here, we will develop next-generation STRs with improved biochemical and pharmacological properties and test their ability to block MYC-dependent gene expression and cell growth in cellular and animal models of cancer.